Molecular mechanisms of caspofungin susceptibility in the pathogen Candida albicans

Candidiasis is the most common fungal infection in the US, with an estimated 63,000 episodes of invasive
candidiasis occurring per year and an estimated cost of $2-4 billion. Candida albicans, the prevalent species,
causes up to 50% of blood infections. Since 2001, C. albicans infections have been effectively treated first with
caspofungin (CAS) and later with other echinocandins (ECNs). However, expanding use of ECNs has led to an
increase in the number of breakthrough infections due to resistance. The only generally recognized mechanism of C. albicans ECN resistance are specific point mutations in the FKS1 gene encoding a catalytic subunit
of 1,3-β-D-glucan synthase complex. Intriguingly, many clinical isolates that are free of FKS1 mutations exhibit
increased minimum inhibitory concentrations (MICs) for ECNs in standard microdilution assays. Our own data
show that direct exposure of C. albicans cells to CAS in vitro generates mutants that lack FKS1 resistance mutations but exhibit decreased CAS susceptibilities and remodeled cell walls. A half of these mutants remain as
normal diploids, whereas the remainder either lose one copy of chromosome 5 (Ch5) or convert one copy of
Ch5 into a chromosome with two right arms (iso-Ch5R). Importantly, expression of 54 genes on disomic Ch5 is
downregulated twofold or more both in the mutants that are normal diploids, suggesting that some of these
Ch5 genes affect CAS susceptibility. We are finding that the newly-discovered mechanisms control same
genes in a similar fashion in vitro and can operate in clinical isolates with decreased ECN susceptibility. Furthermore, DNA-seq analysis of the above model mutants, revealed 2 independent mutational pathways with a
limited number of mutational hot spots. A growing body of factors influencing ECN susceptibilities also includes: a) multiple genes for either negative or positive regulators residing on Ch5; b) the orthologous gene
FKS3, a negative regulator of FKS1 that is downregulated in all types of mutants and in an isolate with increased MICs; c) epigenetic regulation on aneuploid chromosomes that might also operate on disomic Ch5. In
the absence of series of multiple consecutive isolates from ECN-treated patients including drug-naïve isolate
and clinically resistant isolate, characterization of in vitro mechanisms that can decrease ECN susceptibility in
vivo is of a special importance. We propose that the genetic mechanisms discovered in vitro are adaptive initial
changes that decrease ECN susceptibility in clinical isolates and allow survival until a resistance mutation in
FKS1 occurs. To define mechanisms of evolution of ECN resistance we propose to 1) use the information provided by the model mutants to determine metabolic and mutational pathways that are activated in clinical isolates with decreased ECN susceptibility; 2) determine whether epigenetic regulation governs gene regulation
on the disomic Ch5, as well as 3) determine the relevance of mechanisms identified in vitro to evolution of true
resistance in clinical isolates. Our findings will be of high significance to clinicians and researchers investigating the phenomenon of drug resistance in C. albicans.

Public health relevance
Candida infections are often fatal in immuno-compromised individuals, resulting in many thousands of deaths per year. Caspofungin has proven to be an excellent anti-Candida drug, and is now the frontline treatment for infections. However, as expected, the number of resistant cases is increasing, therefore new treatment modalities are needed. We are determining metabolic pathways leading to decreased drug susceptibility in order to identify mechanisms facilitating evolution of clinical resistance. Our study will also reveal genes for new drug targets.